Support for National Conference on Tobacco or Health Conference Activities

The purpose of this activity is to support efforts to plan, coordinate, and implement the National Conference on Tobacco or Health. This conference will be held in Phoenix, Arizona on June 10-12, 2009. These funds will be used for conference support activities to include: arrangements for all facility and equipment rental (including audio/visual, phone lines for computer modems, plenary and breakout rooms), conference materials development and production, shipment of material to the conference site, computer services, speaker-related fees and travel, direct conference-related labor costs, and other miscellaneous direct costs related to subject conference.